Computational Biases of Learning and Decision-Making in PTSD

Project Summary
The goal of this proposal is to characterize novel computational biases in learning and decision-making in
PTSD. The dominant understanding of PTSD emphasizes heightened fear learning and threat detection, and
weakened fear extinction / inhibition. While this model explains many aspects of PTSD, there is a growing gap
between our models of PTSD and the emerging literature defining the normative computational mechanisms of
learning and decision-making. This proposal aims to bridge this gap by defining computational biases in two
clinically-relevant domains of learning and decision-making in PTSD. First, the mechanisms by which
individuals with PTSD prefer avoiding threat at the expense of losing potential reward is not understood. This
bias in approach-avoidance conflict resolution is an essential feature of the clinical presentation of PTSD, and
though threat processing and reward processing have separately been characterized in PTSD, how threat and
reward processing interact to result in biases towards avoidance has never been investigated. Second,
dysregulation of context-depending (i.e., latent state) learning has clear clinical implications in PTSD:
generalization of threat learning outside the trauma context is related to the development of PTSD;
generalization of extinction learning outside of the clinical context is related to the treatment of PTSD.
However, computational models of context-modulated learning have not been used to understand these
processes in PTSD. The current project proposes to use computational modeling of learning and decision-
making in novel tasks that probe the behavioral and brain mechanisms of approach-avoidance biases (Specific
Aim 1) and context-modulated (i.e., latent state) learning (Specific Aim 2). A case-controlled design would be
used, in which healthy adults, trauma-exposed adults without PTSD, trauma-exposed adults with PTSD, and
adults with non-PTSD anxiety disorders would undergo novel learning and decision-making tasks during fMRI
with concurrent psychophysiological assessment. By defining novel computational biases in learning and
decision-making in PTSD, the project 1) would bridge the gap between our understanding of PTSD and our the
growing science of computational mechanisms of learning, 2) has the potential to explain clinically-relevant
features of dysfunction in PTSD, and 3) would provide targets for tracking trajectories of PTSD development
and treatment, and stimulate novel methods for treating PTSD that go beyond the traditional fear conditioning
and extinction models.

Public health relevance
Project Narrative The proposed project would provide important knowledge regarding computational biases underlying threat-and reward-learning, approach-avoidance conflict, and context-modulated learning and recall in PTSD. This important knowledge would bridge the gap between our understanding of PTSD and the growing science of computational mechanisms of learning. This knowledge also has the potential to explain clinically-relevant features of dysfunction in PTSD, would provide targets for tracking trajectories of PTSD development and treatment, and stimulate novel methods for treating PTSD that go beyond the traditional fear conditioning and extinction models.